PROFESSIONAL SERVICES CONTRACT WITH UCSF TO TEST A NOVEL RADIOGRAPHIC ANALYTIC T

PROFESSIONAL SERVICES CONTRACT WITH UCSF TO TEST A NOVEL RADIOGRAPHIC ANALYTIC TECHNIQUE, VOXEL-BASED MORPHOMETRY (VBM) OF THE FEMUR, IN HE AGES-REYKJAVIK STUDY.